Multimodality Intervention to Improve Function and Metabolism in Spinal Cord Injury

Abstract
This application for an administrative supplement requests approval for a one-year extension with partial
funding to enable the completion of this ongoing randomized trial that is currently in its fifth year of funding.
The funded trial aims to test the hypothesis that a multi-modality intervention that includes hybrid exercise plus
testosterone and targets deficits in multiple physiologic organ systems will be more efficacious in improving
musculoskeletal and metabolic health and wellbeing of people living with SCI than hybrid excise plus placebo.
This hypothesis is being tested in a randomized trial in 88 persons with C7 to T12 SCI, AIS grade A, B or C, 6
months or later after SCI. Participants are being randomized to either the multi-modality intervention or hybrid
exercise plus placebo for 16 weeks, stratified by age, sex, and AIS grade. After 2-weeks of training in the
exercise laboratory, the intervention is conducted in the participant’s home, using video monitoring of the home
exercise. Primary outcome is peak aerobic capacity. Secondary outcomes include self-reported function and
mobility assessed using computerized adaptive test version of Spinal Cord Injury-Functional Index; muscle
mass and strength; fat mass and fat distribution; insulin sensitivity; lipids; inflammatory markers; and wellbeing
(mood, anxiety, pain, and life satisfaction). The aims or the design of the funded trial have not changed.
Very shortly after the trial's initiation, the sudden onset of the COVID pandemic led to nationwide shutdown of
most non-covid clinical research activities. Due to the complete shutdown of clinical research for several
months in 2022 followed by slow ramp up of clinical research activities in 2020 and 2021 due to multitude of
factors that are discussed in the application, the enrollment in the trial suffered. In spite of these COVID-related
challenges, the enrollment in the trial during the past year has increased substantially and the current
enrollment rate exceeds that projected in the original grant application. Therefore, the parent as well as the
supplemental bone study are on target for completion in the coming year. An additional year of partial support
of the project would enable completion and close-out of the trial, accomplishment of all the proposed aims of
the project, and accrual of full returns on the NIH's generous investment in this important project of high priority
to people living with a SCI.
Spinal cord injury (SCI) is one of the most grievous conditions that greatly impairs a person's mobility, function,
overall health, and wellbeing, and increases healthcare resource utilization and costs and caregiver burden.
The National Center for Medical Rehabilitation research has designated “pharmaceutical, stimulation, and
exercise…strategies to improve motor function and health of SCI patients” a priority area of research. Because
all components of the multimodality intervention are commercially available, the findings of this innovative trial
upon its completion could be expeditiously translated into clinical practice and improve the health and
wellbeing of people with SCI.

Public health relevance
Narrative This administrative supplemental application requests a one-year extension of this grant with additional funding to enable completion of the ongoing randomized trial of a multimodality intervention to improve function and metabolism in people living with spinal cord injury. The parent trial is a randomized, placebo-controlled trial to determine the efficacy of a Home-Based Multimodality Functional Recovery and Metabolic Health Enhancement Program that includes hybrid exercise training (FES-LC and arm ergometry), and testosterone in improving aerobic capacity, muscle mass and physical performance, metabolic health, self-reported function and mobility, areal and volumetric bone mineral density and microarchitecture, and wellbeing. The one-year extension was necessitated by the nationwide mandatory suspension of clinical research activities due to the COVID-19 pandemic and the subsequent slow ramp up of clinical research due to COVID-related restrictions and is necessary for completion of the trial and for accruing the full return on the NIH investment in this important and innovative trial.